The Second International Conference on Learning and Memory (LEARNMEM2023)

ABSTRACT
Learning and memory are key to understanding brain function and dysfunction. While there have been
extraordinary advances in this area, insufficient emphasis has been placed on vertical integration across
approaches. As a result, little progress has been made in translating findings to the treatment of neurological
disorders. This was the motivation behind the 1st International Conference on Learning and Memory
(LEARNMEM2018) five years ago, which was a tremendous success. We will hold the 2023 International
Conference on Learning and Memory (LEARNMEM2023), which will be held at the Waterfront Beach Resort in
Huntington Beach, CA on April 26-30, 2023, in celebration of the 40th Anniversary of the UC Irvine Center for
the Neurobiology of Learning and Memory (CNLM). The conference will feature plenary talks by distinguished
neuroscientists as well as midcareer and early career rising stars, diverse and balanced symposia, short talks,
poster sessions, panel discussions, workshops, and professional development opportunities for early-stage
investigators. We have also been selected to host the USA Brain Bee 2023, which will be integrated into the
conference as one of our key community engagement events. Anticipated attendance is 1200-1500 and the
conference is open to everyone. In every facet of the conference, we place special emphasis on
multidimensional diversity of contributions across gender, race, seniority, country of origin, and level of
analysis. Our aims are to (1) Identify knowledge gaps and opportunities for scientists, clinicians, nonprofits,
businesses, and community members to share and discuss cutting-edge research on learning and memory in
a fully integrative fashion through invited plenary talks and panels, as well as submitted symposia, short talks,
and posters; (2) Train the next generation of leaders in the neuroscience of learning and memory by providing
numerous networking and professional development opportunities for early career researchers, with a special
focus on scientists from backgrounds underrepresented in neuroscience; (3) Disseminate knowledge by
publishing the proceedings of the conference, engaging contributors in a special online research topic, writing
consensus papers and co-authored reviews, as well as video-recording all lectures, symposia, and short
presentations for widespread dissemination; and (4) Engage the community by opening the conference to non-
scientists and encouraging their attendance, as well as hosting special events to facilitate engagement
between scientists and community members across all levels from schoolchildren to retirees. With support
from this R13 we will be able to provide up to 20 travel awards to competitively selected early career scientists
who are from historically underrepresented groups and demonstrate outstanding potential for a career in
neuroscience. LEARNMEM2023 will have substantial impact on the field by accelerating the pace of team
science and providing a unique opportunity to train the next generation of leaders in neuroscience.

Public health relevance
PUBLIC HEALTH NARRATIVE Neurological and neuropsychiatric illnesses are prevalent and debilitating, affecting more than a quarter of the global population. Learning and memory are implicated in every neurological illness from stroke to Alzheimer’s disease and every neuropsychiatric dysfunction from depression to drug addiction, however integration across approaches and models is critical for effective translation to treatments and therapies. LEARNMEM2023 is the 2nd ever International Conference on Learning and Memory, which will foster integration among the field’s scientists and train the next generation of leaders in neuroscience in interdisciplinary dialogue and collaboration.